Strengthening Retail Food Regulatory Programs and Reducing Foodborne Illnesses through National Partnerships

Project Summary
The Association of State and Territorial Health Officials (ASTHO) will establish an operational
framework with the Retail Food Safety Collaborative (Collaborative) that will be based on a
mutually beneficial and well-defined relationship to achieve common goals in retail food safety.
ASTHO, in partnership with the retail food regulatory associations, will support the
Collaborative’s six specific aims:
1. Develop a national Food Code adoption strategy, including the Food Code Adoption
Tool Kit.
2. Improve the approach, competency, and food safety culture in the regulatory
community.
3. Increase enrollment, engagement, and conformance in the Voluntary National Retail
Food Regulatory Program Standards (Program Standards).
4. Improve foodborne outbreak investigation methods.
5. Increase the number of establishments that have well-developed and implemented Food
Safety Management Systems.
6. Develop a strategy to enhance communication and better tell our collective story.
This proposal’s overall objective is to support and enhance efforts by the Collaborative to
reduce the incidence of foodborne illness. ASTHO plans to meet this objective by carrying out
discrete activities focused on the six specific aims and by engaging ASTHO’s membership
(state and territorial health commissioners) and four important ASTHO peer networks: 1) Public
Health Lawyers Peer Network, 2) State/Territorial Legislative Liaison Peer Network, 3)
State/Territorial Environmental Health Directors and 4) State Tribal Liaisons Peer Network.

Public health relevance
Project Narrative State and territorial health agencies, along with other governmental agencies, help regulate food preparation, sale, and distribution, in addition to being primary responders to outbreaks of foodborne illness. The Centers for Disease Control and Prevention (CDC) estimates that 48 million people get sick, 128,000 are hospitalized, and 3,000 die from foodborne diseases each year in the United States. This demonstrates a serious strain on the food safety system and has led the public health community, including the Food and Drug Administration (FDA), to launch a Retail Food Safety Initiative to help achieve a better coordinated prevention-oriented food safety infrastructure. Through the activities in this proposal, ASTHO will further align its goals to that of FDA’s Retail Food Safety Initiative and work collaboratively with the Retail Food Regulatory Association Collaborative and help facilitate long-term improvements to the national food safety system.